Team-Based Virtual Field Exercises for HAZMAT Training

Summary/Abstract
Among the most educationally valuable components of in-person 40-hour HAZMAT courses are team-based field
exercises. This capstone activity combines skills and protocols into an experiential exercise in which learners practice
different roles (e.g., entry team, decon team, site supervisor) and equipment (e.g., PPE, sensors, communications).
Team-based HAZMAT training exercises have been found to yield statistically significant improvements in preparedness
when compared to individual non-collaborative training. However, for several reasons, the more frequent 8-hour
refresher courses lack team-based field exercises. First, set-up/tear-down time for such an exercise (~1 hour) would
consume a significant amount of the 8 hours. Second, in response to pandemic protocols and emerging worker and
instructor preferences, training organizations now offer most 8-hour refresher courses virtually in a synchronous online
format. Third, HAZMAT video simulators are currently single user games with no interactivity between learners, and
require each training organization and learner to install expensive video game software - and sometimes hardware like
VR goggles. Instead, instructors use a case study approach whereby certain aspects of a current hazardous waste site
are revealed to the students, who then are required to discuss how they would respond. This is far from experiential.
The proposed effort develops a web-based teaching tool that brings the pedagogical value of the physical team-based
in-person field exercises of 40-hour HAZMAT courses to the virtual 8-hour refresher courses. The proposed experiential
worker training tool exploits recent advances in web standards in order to achieve multiple significant innovations. First,
it is the first browser-based HAZMAT training tool to provide team-based HAZMAT field exercises. Thus, any person or
training organization with a web-enabled device can use the tool, and no installation of hardware or software is
required. Second, the training tool is intuitive. Team members in the virtual field exercises communicate via Zoom,
which is integrated with the teaching tool. Third, every student experiences her/his individual realistic and immersive
3D view of the common training scenario, including a virtual chemical and radiation exposure sensor. Fourth, as with in-
person exercises, the instructor has the ability to dynamically interject events during the exercise, such as change in the
intensity of a hazardous spill or on-the-spot questions, to assess students and keep them engaged.
This proposal is based on requests from several training and community organizations, including participants of the 2022
Bi-Annual Midwest Consortium Trainer Conference. Cell Podium will work closely with the following five HAZMAT
worker training centers to meet their specific requirements and to deploy in their courses several iterations of the
prototype teaching tool for evaluation: the Center for Public Health Workforce Development (Rutgers School of Public
Health), the Midwest Consortium for Hazardous Waste Worker Training, the Environmental Management Institute
(Indiana), the Green Door Initiative (Detroit), and the UCLA Labor Occupational Safety and Health Program. The ultimate
goal of the proposed effort is to develop a tool that is adopted by the HAZMAT training community, enriches online
training, and improves the preparedness of our HAZMAT workers.

Public health relevance
Narrative With advanced yet low-cost 3D web technologies, the training tool developed and tested by this project will empower HAZMAT instructors to conduct virtual team-based field exercises, and provide workers with the experiential capstone experience and preparedness they currently can only get through in-person 40-hour HAZWOPER courses. This tool will also further improve the quality of training programs that exceed the NIEHS WTP minimum criteria, and differentiate them from programs that do not.